Developing extracellular vesicle-mediated targeted microRNA delivery system for EGFR cancers

Title
Developing extracellular vesicle-mediated targeted microRNA delivery system for EGFR cancers
Project Summary
Targeted therapy acts on a well-defined molecular mechanism of disease pathologies within a tissue or cells.
However, many clinical trials encountered insufficient efficacy or safety issues due to accumulating in unwanted
organs or off-target effects. One such molecule, microRNA(miRNA), is a small non-coding RNA that plays a
critical role in tumor biology, including tumor progression, drug resistance, and metastasis, through sequence-
specific translational regulation. While miRNAs hold a promising therapeutic potential, the adverse events
resulting from severe immunogenic responses terminated the clinical trials. Thus, an efficient delivery system is
essential to establishing miRNA therapy. This project aims to establish a targeted therapeutic miRNA delivery
system using engineered cell-derived extracellular vesicles (EVs). EVs are the body's natural biomolecular
transporters that could overcome various issues associated with existing delivery systems. Specifically, we will
engineer EV surface with antibody mimetics (monobody) to target Epidermal Growth Factor Receptor (EGFR)
cancer to deliver tumor suppressor miRNAs. We hypothesize that EVs can efficiently deliver miRNAs into EGFR+
cells, where the miRNAs will exert powerful anti-tumor effects. Following the EV generation, we will demonstrate
that these miRNA packaging EVs will have EGFR tumor specificity and anti-tumor effects. This will build a
foundation for EV-based targeted delivery of miRNA-based therapies. We expect our approach to offer new
possibilities for cancer treatment by utilizing EVs with low immunogenicity, cytotoxicity, and efficient miRNA
release. These validations will empower and accelerate the development of EV-based targeted therapeutic
delivery.

Public health relevance
Project Narrative A tremendous problem in molecular therapeutics is the difficulty in targeting specific cell types or diseased cells within healthy tissue due to the lack of efficient delivery methods carriers that do not provoke an immune response or evade endosomal capture. In this project, new technology will be developed to utilize extracellular vesicles (EVs) as molecular cargo to deliver molecular therapeutics and to uncover the EV-cell interaction and delivery. This project aims to demonstrate the proof-of-principle of an EV-mediated therapeutic delivery system applicable to diverse diseases awaiting targeted therapeutic delivery for clinical application into EGFR-type tumors resistant to existing therapeutics by targeted delivery and efficacy in vivo.